2024 Drug Metabolism Gordon Research Conference and Gordon Research Seminar

Abstract
To deeply understand the pharmacology and toxicology of a molecule, whether it be a drug, endogenous
chemical, or a natural product, the Absorption, Distribution, Metabolism, and Excretion (ADME) properties for
the molecule must be known. ADME has a tremendous influence on efficacy, safety, and dosing of therapeutic
agents. Thus, ADME science is at the core of translating basic science discoveries into effective therapies in
the clinic, optimization and individualization of drug therapy, and informing clinical and regulatory decision
making. There is unprecedented diversity in the approaches available for research and discovery of new
treatments for disease. The pace of discovery has increased immensely, and an epic expansion of new
knowledge and therapeutic modalities is well underway. In this 52nd meeting of the Drug Metabolism Gordon
Research Conference we will embrace the foundational character of ADME science as a guiding force in what
is now a multiverse of scientific discovery consisting of grand diversity. ADME science is characterized as
being highly integrative, multidisciplinary, and based on structural, mechanistic, kinetic, quantitative, and
computational approaches to predict and translate molecular discoveries to effective clinical application. At the
forefront will be the presentation and discussion of research that embraces these foundational characteristics
and their application to: 1) metabolite identification, pathways, and distribution, 2) ADME enzymes and
transporters, 3) protein degraders, and 4) interpretation/application of fraction unbound for drug clearance
prediction. We will share cutting-edge science and emphasize the importance of interconnectedness among
disciplines so that we fully embrace the potential of emerging technologies to inform ADME studies,
technologies such as mass spec imaging, cryogenic electron microscopy, new methods for drug-drug
interaction prediction, and microphysiological devices. The conference will bring together academic, industry
and regulatory scientists at all career stages and provide a stimulating and welcoming environment to discuss
unpublished research. The informal venue with communal dining and housing provides an ideal environment to
establish this. This conference will provide a forum for early career scientists to interact with leaders in their
respective fields, expand their knowledge, establish collaborative relationships, and consider various career
paths. Scientific sessions are held in the mornings and evenings over 4.5 days with the afternoons available for
informal discussions and recreation. GRC meetings are small and designed for more discussion time during
both the formal scientific sessions and during informal interactions (e.g., poster sessions, mealtimes, afternoon
outings). To facilitate ample opportunity to discuss their work, the Drug Metabolism GRC organizes four, two-
hour poster sessions, with each poster presenter (at least 60) available for discussion during two sessions. The
2-day Gordon Research Seminar will precede the main GRC conference. It provides a unique environment for
students and early career scientist to present, connect and access mentoring.

Public health relevance
Project Narrative The 2024 Drug Metabolism Gordon Research Conference (GRC) is titled Character Is Fate: Navigating the Multiverse of Discovery Through ADME Science. The conference will focus on cutting-edge advancements and mechanistic discoveries in the science of Absorption, Distribution, Metabolism and Excretion. This is pertinent to public health because communication about advances in ADME science aids in the discovery, development, and safe use of diverse drug modalities.